Modulation of the Perineuronal Net Protein Brevican in the Nucleus Accumbens, and its Impact on Addiction-related Behavior

Project Summary
Psychostimulant drugs of abuse induce persistent functional changes in the neural reward circuitry that
underlie the development of addiction. These regions include the nucleus accumbens (NAc), a key area for
drug reward. Growing evidence suggests that altered interneuron function in NAc makes key contributions to
the drug-induced circuit adaptations leading to addiction behaviors. We have shown that NAc parvalbumin-
expressing (PV+) inhibitory interneurons are required for multiple addiction-related behaviors in mice, including
amphetamine (AMPH)-induced locomotor sensitization and conditioned place preference (CPP). Others have
shown that cocaine self-administration strengthens excitatory inputs from basolateral amygdala onto NAc PV+
interneurons, and artificially potentiating these synapses accelerates acquisition of cocaine self-administration
in naïve mice, suggesting that synaptic plasticity in NAc PV+ interneurons is behaviorally relevant for the
development of addiction-like behaviors. However, little is known about the molecular mechanisms by which
psychostimulants alter PV+ inhibitory interneuron function, and how this contributes to addictive behaviors. A
promising mechanistic target is the perineuronal net protein Brevican (Bcan), which plays a cell-autonomous
role in stabilizing excitatory inputs onto PV+ interneurons. The overarching goal of this proposal is to test the
hypothesis that repeated psychostimulant exposure modulates PV+ interneuron activity through regulation of
Bcan expression. In Aim 1 I will characterize the regulation of Bcan expression in NAc PV+ interneurons over
the development of AMPH CPP. In Aim 2 I will test how manipulating Bcan expression affects the synaptic
inputs to these neurons. In Aim 3 I will test the effect of manipulating Bcan in NAc PV+ cells on the threshold
to develop CPP. These studies will investigate cellular transcriptional and synaptic plasticity mechanisms
within PV+ interneurons, and how they affect the expression of addiction-related behaviors.

Public health relevance
Project Narrative Drug addiction is a complex and seemingly intractable disorder that exacts enormous financial and personal costs upon society. Repeated exposure to drugs of abuse leads to addiction by inducing long-lasting functional changes in neural reward circuitry. This study will investigate novel molecular mechanisms of cellular interneuron plasticity that impact reward circuit function and addiction-related behaviors, using mice as a genetically tractable experimental model system, and may identify druggable targets for future treatments to combat the destructive cycle of drug addiction.